Small intestinal remodeling across pregnancy cycles

PROJECT SUMMARY
Pregnancy represents a developmental window of profound change across virtually every tissue in the maternal
body. While central roles for the uterus and mammary gland in this process are well established, we lack
fundamental knowledge about the cellular changes that occur at other sites and how they affect short- and
long-term maternal health. In this work, we will investigate tissue remodeling in the small intestine; an organ
that must increase its nutrient uptake massively to absorb an estimated excess of 50,000 kcal throughout
human pregnancy and 500 kcal per day during lactation. While gross anatomical changes of the intestine during
pregnancy have been documented for decades, and reduced intestinal motility is one of the most common
pregnancy symptoms, the cellular, molecular, and tissue-level mechanisms that remodel the intestine at this
stage are not understood. The goal of this project is to identify unique aspects of the pregnant body that
stimulate stem cells and drive intestinal remodeling to support maternal physiology. Cardiovascular disease,
diabetes, and other metabolic disorders are among the leading causes of maternal morbidity and mortality
during and in the year after pregnancy. We will use pregnancy as a model to study fundamental principles of
tissue regeneration, while providing urgently needed insights into the poorly understood biology that underlies
rising incidences of these pregnancy-associated diseases. The New Innovator Award would allow me to apply
my expertise in epithelial tissue regeneration and nutrient metabolism to establish an urgently needed baseline
of mechanistic understanding of the programs that remodel maternal digestive organs during pregnancy.

Public health relevance
PROJECT NARRATIVE The goal of this work is to identify how the gastrointestinal system supports the increased metabolic demands of pregnancy. Findings from this study will provide urgently needed insights into the poorly understood short- and long-term changes in the maternal body that may contribute to rising incidences of pregnancy-associated morbidity and mortality.